DAMPs Across the Tree of Life Inducing Innate Immunity

ABSTRACT Support is requested for a Keystone Symposia conference entitled DAMPs Across the Tree of Life Inducing Innate Immunity organized by Drs. Seung-Yong Seong, Zhijian Chen, Walter G. Land and Polly Matzinger. The conference will be held in Republic of Korea from September 21 - 25, 2020. Injury-induced Damage Associated Molecular Patterns (DAMPs) are beginning to shape modern medicine in the field of both diagnostics and therapeutics. For example, DAMPS are already recognized to be major contributors to rejection in the field of transplantation, and efforts are underway to target them. Research is showing that they can also contribute to rejection of tumors, for example with immunogenic cell death, and efforts are underway to stimulate them for cancer eradication. With their use, new vaccination modalities will be developed against viral infections, including HIV and ZIKA virus. Further, DAMPs-based innovative diagnostic methods and new therapeutic strategies will soon improve survival rates of critically ill patients, such as those who have undergone major trauma. Due to its involvement in autoimmune diseases, chronic inflammatory diseases, and allergic diseases, as well as plant resistance to predators, initiation of innate immune responses by DAMPs is currently a thriving research area. It covers both medical and agricultural fields. The goal of this conference is to convene internationally renowned experts from academia, biotech and pharma, in fields reflecting the diversity listed above, to present and discuss their latest findings in DAMPs research and applications.

Public health relevance
PROJECT NARRATIVE Damage-associated molecular patterns (DAMPs) are molecules released by stressed cells undergoing necrosis that act as endogenous danger signals to promote and exacerbate the inflammatory response. As injury-induced DAMPs are beginning to shape modern medicine in the field of diagnostics and therapeutics, sophisticated methods and technologies are needed to understand the molecular nature of DAMPs. Therefore, this conference will bring together a variety of scientists studying the DAMPs in different lifeforms from animals to plants, to discuss the latest research and therapeutic strategies that will soon help to improve survival rates of critically ill patients, such as those who have undergone major trauma.